Targeting NMDA Receptors and Brain Estradiol to Rescue Memory in Aging Females

PROJECT SUMMARY/ABSTRACT
Aging women are disproportionately affected by severe memory loss and Alzheimer's disease (AD). The precise
mechanisms that impair memory in older women are not fully understood, but the transition into menopause at
middle-age, and the ensuing decrease in circulating estrogens, is a consequential inflection point of the female
lifespan. Numerous studies document an association between the loss of ovarian hormones, especially estradiol
(E2), at menopause and the loss of their protective effects on neural health and cognition. Under normal
circumstances, E2 acts upon NMDA receptors (NMDARs) that are essential for learning and memory. In the
context of brain disorders, NMDARs gate excitotoxic signaling that can exacerbate neurodegeneration. Loss of
E2 in the brain is plausibly situated to influence shifts in NMDAR contributions to neuronal signaling versus
survival in brain aging and moderate the effects of AD therapeutics. Consequently, there is a pressing need to
develop targeted therapeutics to precisely restore brain E2 and NMDAR activity that could reverse memory loss
and reduce AD risk in older, post-menopausal women. Consistent with this view, our preliminary data reveal that
a novel therapeutic that potentiates NMDAR function reverses memory loss in older male rats but not in age-
matched female rats. The goal of this project is to determine the mechanisms by which female sex and E2 loss
accelerate age-related decline of memory and NMDAR functions and to rejuvenate brain E2 levels and sensitivity
to NMDAR-directed drugs to rescue memory in older, hormone-deficient females. This project will use normally
aging rats to 1) compare effects of approved and novel NMDAR therapeutics on brain and behavior of aging
male and female rats and 2) investigate the effects of whole body and brain-specific replacement of E2 in
surgically estrogen-deficient, aging females. These studies of NMDAR-directed compounds in well-controlled
animal models of aging and estrogen deficiency will be significant because they can provide the necessary
mechanistic insights to guide the translation and development of new, targeted therapeutics to prescribe to peri-
and post-menopausal women at risk for age-related memory disorders. More broadly, identifying sex-specific
and age-appropriate strategies to decelerate fundamental mechanisms that drive neuronal and cognitive aging
will broadly improve health outcomes for older women who comprise the largest fraction of those at-risk for AD.
These objectives are within the scientific scope of the University of South Carolina's COBRE on Targeted
Therapeutics, contribute a unique and distinct complement to ongoing studies of NMDAR-directed therapeutics,
and will accomplish rigorous scientific research on differential rates of cognitive aging and the underlying
mechanisms of aging leading to increased risk of Alzheimer's disease in pre- and post-menopausal women,
specific areas of interest for the National Institute on Aging related to Women's Health.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it centers on strategies to prevent age-related memory loss and Alzheimer’s disease in post-menopausal women, who are more susceptible to these disorders than similarly aged men. Specifically, this research project will test new therapies that augment synaptic neuro- transmission and brain estrogen levels and measure effects on memory in aging females. The proposed re- search is relevant to NIH’s mission to understand processes that lead to differential rates of aging and increased risk of disease in post-reproductive women.